METHIONYL HGH IN SUBJECTS WITH GH FAILURE ASSOCIATED WITH GH DEFICIENCY

Patients who are GH deficient will receive MET-GH at a dose of 0.1 mg(0.2 units)/kg b. wt. tiw for 12 months. The efficacy will be determined by serial measurement. Toxicity will be determined by laboratory testing (antibodies, liver function tests, CBC, SMAC); patients return q 2 months.